Breaching the Gram negative bacterial cellular envelope

The cellular envelope of GN bacterium, consisting of the outer membrane, inner membrane, and an array
of specific and multidrug efflux transporters, presents a formidable barrier for the development of antimicrobials
with cytosolic targets. Insight into the physicochemical properties that enable the entrance of compounds is
critical to direct future effort in the development of effective treatment against GN pathogens. Toward this goal,
methods to accurately quantify the accumulation of small molecule compounds, independent of their
antibacterial activity, will be developed. Compound accumulation in Acinetobacter baumannii, an ESKAPE
pathogen, will be determined. In addition, novel computational algorithms will be developed to explore the
chemical space, describe and predict physicochemical properties that favors entry and evade efflux in GN
bacteria. The computer model will be validated and modified through the selection and characterization of
hundreds of compounds. Specifically, the following aims will be pursued: Aim 1) To develop and validate
assays to quantify compound partition. A panel of commercially available antibiotics will be used to develop
and validate assays to accurately determine the accumulation of small molecule compounds in different
cellular compartments of A. baumannii using LC/MS/MS. The contribution of efflux and OM obstruction will be
dissected using strategic mutant strains. These assays will be used in combination of in silico evaluation of
compound accumulation, and experimental data will feed into the screening and modeling effort to iteratively
improve the computational algorism. Aim 2) To develop a computational algorithm to identify compounds that
are potentially good penetrators for GN bacteria and elucidate the role of permeability and efflux. A new and
highly accurate computational algorithm through machine learning will be developed, which can systematically
recognize all favorable structural factors of the compounds effective for GN bacteria. In addition, candidate
compounds emerge from the analysis will be subjected to MD simulation to further analyze their potential
interaction with the major efflux transporter. Selected compounds will be experimentally characterized in Aim 3,
the knowledge from which will be incorporated back into refining the computer algorithms to generate a new
round of learning/prediction. This cycle will be repeated three time, with the testing of 300-400 compounds
each cycle. Aim 3) To measure the accumulation and subcellular distribution of selected compounds and to
validate rules on compound accumulation. With the assays from Aim 1, the accumulation data of compounds
selected through Aim 2 will be determined. Data from these analyses will be used to further polish the
computer algorisms in Aim 2. Structure features that facilitate accumulation in GN bacteria will be derived.
Outcome from the proposed study will help bridge the gap between a potent inhibitor and an effective
antibacterial drug. The combined use of the detailed experimental assays and the new computational algorithm
will empower drug discovery efforts that aim to identify promising drug candidates targeting GN bacteria.

Public health relevance
The development of new antimicrobials has drastically lagged behind the fast growth of drug resistant pathogenic microbes, especially for Gram-negative (GN) bacteria. Insight into the physicochemical properties that enable the entrance of compounds is critical to direct future effort in the development of effective treatment against GN pathogens. Outcome from the proposed study using the combination of detailed experimental assays and new computational algorithm will empower drug discovery efforts that aim to identify promising drug candidates targeting GN bacteria.